Program Leadership

Program Leadership. Cancer care and cancer research are inextricably linked. Dual leadership is critical to translation of any discovery, clinical or basic, in brain tumor science. Drs. O'Neill (clinical-translational) and Loftus (translational-basic) oversee the research direction of the Program.